Orthopaedic Trauma Association - Basic Science Focus Forum

ABSTRACT
The Orthopaedic Trauma Association (OTA) was established in 1977 to address the unique challenges faced by
orthopaedic surgeons caring for patients with extremity fractures. The OTA has grown substantially since its first
meeting, with 2766 current members. The Basic Science Focus Forum (BSFF), a critical component of the OTA
Annual Meeting, serves as the premier forum for integrating clinical, translational, and basic science
research in orthopaedic injury. The BSFF has evolved into a collaborative platform that fosters cross-
disciplinary knowledge transfer and drives innovation among researchers and clinicians at various career stages.
Held as a pre-meeting event to the OTA Annual Meeting, the Annual BSFF Conference maintains a consistent
structure while evolving its content to reflect current research priorities, including infection mechanisms, fracture
healing biology, systemic effects of traumatic injuries, and emerging technologies. Each meeting features
internationally recognized speakers from diverse scientific organizations, promoting valuable cross-disciplinary
discussions through focused symposia alongside original research paper and poster sessions. The 2025 BSFF
Meeting will take place on October 15, 2025, at the Phoenix Convention Center in Phoenix, AZ, and feature three
scientific symposia addressing how cutting-edge technology and research in orthobiologics, Artificial Intelligence,
and fracture-related infection impacts patient care. Future annual meeting venues include Nashville (2026) and
New Orleans (2027). Over the last decade, the OTA Annual Meeting has experienced significant growth in
attendance and scientific content, resulting in competing demands between the BSFF and expanded event
options for OTA attendees. This has created financial challenges for maintaining the relationship between clinical
practice and basic science research. As such, for the 2025 Annual Meeting, the OTA leadership has committed
to trial the elimination of separate registration costs for the BSFF. The BSFF's integration into the general
registration process is projected to increase attendance by >30%, particularly among early career investigators.
The requested NIAMS R13 funds for the next three years will offset a portion of the operational costs to make
this approach sustainable while maximizing accessibility, strengthening the connection between translational
research and clinical practice that is essential for advancing orthopaedic injury research. The OTA BSFF content
and conference goals directly aligns with the mission of NIAMS by fostering cross-disciplinary interaction,
innovation, and improving patient care.

Public health relevance
NARRATIVE Founded in 1977, the Orthopaedic Trauma Association (OTA) has grown into an organization of 2,766 members dedicated to addressing challenges in treating extremity fractures. The Basic Science Focus Forum (BSFF), a key component of the OTA Annual Meeting, serves as the premier platform for integrating clinical, translational, and basic science research in orthopaedic injury through collaborative discussions, symposia, and podium/poster presentations. For the 2025 meeting in Phoenix, the OTA leadership will trial eliminating separate registration costs for the BSFF to increase attendance and strengthen the connection between research and clinical practice, with the requested NIAMS R13 funds helping to sustain this approach over the next three years.